Comparative analysis of DNA damage and repair capacity in dogs to improve cancer risk prediction

Project Summary/Abstract
Dogs have a higher incidence of cancer than humans (8041 versus 457.52 per 100,000 dog- or person-years),
and accumulate somatic mutations much more quickly than humans do (as somatic mutation rates scale with
lifespan)3. The mechanism(s) of this higher cancer predisposition and faster rate of somatic mutation are not
yet known. Dogs are an important biomedical model for human cancers, and are leveraged in precision
oncology studies, preclinical drug development, and as environmental sentinels of genotoxic exposures.
Elucidation of the mechanism of increased somatic mutation will improve the utility of the dog as a cancer
model and environmental sentinel, and help to lay the foundation for leveraging canine cancers to develop
precision cancer risk prediction in people and understanding factors that modulate cancer risk.
This study explores the hypothesis that the increased rate of somatic mutation arises via contributions from:
(1) increased exposure to endogenous or exogenous genotoxins causing DNA damage; (2) deficiencies in
DNA damage repair capacity (DCR); or (3) failure of cells with somatic mutations to undergo apoptosis. To
distinguish among these possibilities, I will test normal primary T-lymphocytes isolated from both healthy dogs
and dogs with T-cell lymphoma. Cells will be placed in primary culture and T-lymphocytes stimulated using
established protocols in routine use in my mentors’ labs. In each of the analyses described below, I will
compare findings between dogs with and without lymphoma, quantify variation between and within individuals
and breeds, and compare findings to published human data.
This study also provides a comprehensive training plan allowing me to: gain expertise in functional DNA
damage assays including CometChip and FM-HCR; become proficient in cell isolation and cell culture
techniques; learn to sort and analyze cells via flow cytometry; extend my genomics expertise to include
somatic variant detection in normal tissues, gain expertise in DNA damage repair mechanisms and
environmental health; and broaden my experience as mentor and teacher.
By elucidating the mechanisms behind increased somatic mutation in dogs, as well as characterizing DNA
damage repair kinetics and the somatic mutational landscape of normal canine cells, this work will make
crucial contributions to our understanding and leveraging of dogs as a model for human cancers. In addition,
the proposed training program, under the supervision of a team of outstanding mentors, will enable me to
augment my computational genomics skills with powerful wet lab and novel sequencing techniques, positioning
me for a successful career as an independent biomedical scientist.

Public health relevance
Project Narrative Dogs, an important biomedical cancer model, have an increased rate of somatic mutation relative to humans, but the mechanism driving this increase in mutation and overall cancer risk remains unknown. The goal of this study is to test whether there are differences in (1) baseline oxidative damage and reactive oxygen species, (2) DNA damage repair kinetics and rates of cell death; and (3) to characterize longitudinal changes in somatic mutations in normal cells. Understanding the causes of increased rate of somatic mutation will improve the utility of the dog as a precision cancer model and environmental sentinel, and reveal key determinants of cancer risk.